Linking PAH Exposure to Health Outcomes Using Human Primary In Vitro Respiratory Model

PROJECT SUMMARY – TILTON PROJECT
One of the most difficult challenges for environmental health assessment is to evaluate hazards from exposure
to chemical mixtures. The environmental health science community recognizes polycyclic aromatic
hydrocarbons (PAHs) as a re-emerging class of environmental pollutants due to their persistence and
prominence in mixtures of concern; however, little data exists for structurally diverse PAHs and their
transformation and breakdown products in complex mixtures. In particular, alkylated PAHs (a-PAHs) appear
abundantly in environmental samples from multiple sources, including petrochemicals associated with
Superfund sites and thermal decomposition of organic matter. To assess risk to relevant populations, it is
important to understand how PAHs contribute to toxicity in mixtures using human-relevant and metabolically
competent research models and to establish a relationship between chemical exposure and toxicity. This
Biomedical Science Research Project will rely on a 3D human lung model composed of primary human bronchial
epithelial cells differentiated at the air-liquid interface to assess the toxicity of PAHs in complex mixtures
associated with multi-source exposures near Superfund sites. To quantify the toxicity of PAHs in lungs, we will
measure the threshold response using benchmark dose modeling and identify the mechanisms by which PAHs
exert adverse health outcomes in exposed populations. The overall goals of this project are to assess the toxicity
of novel PAHs alone and in mixtures from combined sources of exposure near Superfund sites, to advance
organotypic models for improving extrapolation and risk assessment from in vitro systems, and to understand
risk for toxicity in susceptible individuals. We will apply the outcomes of these studies to assess and communicate
human health risks, including to vulnerable populations. We propose to achieve these aims: 1) quantify toxicity
of novel substituted PAHs as components of multi-source exposures in the 3D human lung model, 2) assess
chemical drivers of in vitro toxicity from complex mixtures linked to in vivo exposures via effects-directed
analysis, and 3) identify endpoints that predict PAH toxicity in susceptible individuals in order to assess toxicity
from combined risk factors.

Public health relevance
PROJECT NARRATIVE – TILTON PROJECT Critical data gaps exist regarding toxicity of the broader class of structurally diverse, substituted PAHs and the ways in which PAHs contribute to toxicity of mixtures for effective evaluation of human health risk. Our innovative approach to address these knowledge gaps is to assess toxicity in a metabolically competent human 3D lung model with studies that link PAH exposure to toxicity in humans from in vitro phenotypic, mechanistic and metabolic data. These studies will make it possible to assess and communicate human health risk and to evaluate susceptibility for relevant populations.